Coordinating Center

NETWORK COORDINATING CENTER – PROJECT SUMMARY / ABSTRACT
The Medical Rehabilitation Research Resource Network (Network) is NCMRR’s main vehicle for supporting
rehabilitation research infrastructure. Thus, the proposed goal of the Coordinating Center (CC) at the National
Center of Neuromodulation for Rehabilitation (NC NM4R) is to maximize Network potential by catalyzing
activities to promote cross-center and multi-stakeholder communications, support central web portal and
directory services, ensure strategic network-wide activities to increase impact on rehabilitation research and
support NCMRR with central data collection and outcomes analyses. CC will build upon extensive infrastructure
and decades of MUSC experience in informatics, team science, distance learning, event management, and
communications to create a coordinating center that is responsive to current Network. We will implement both
traditional and innovative approaches to make rehabilitation research highly visible; empower scientific teams
and the Network to impact RPR priorities; and connect active stakeholders. We will do so via the following
Specific Aims. AIM 1. Develop a Network web portal. There is a need for a central Network web portal to
provide a unified point of entry, and central catalogue, for rehabilitation researchers to access Network resources
versus the current environment where researchers must navigate to each center’s website to find applicable
resources. We envision an entry point that would allow a user to more easily see offerings across centers (e.g.,
unified directory of core resources, unified calendar of training events, unified list of funding opportunities, etc.).
AIM 2. Coordinate trans-center activities. We will develop a dynamic ecosystem to support effective, efficient
and coordinated communications across the Network and to external stakeholders. AIM 3. Foster development
of collaborative strategies to support Network impact on RPR. We propose a number of innovative strategy
and communications opportunities aimed at optimizing network impact such as: 1) Face-to-Face Strategic
Retreats: These one- or two-day meetings would convene key center leadership members and be dedicated to
identifying multicenter and network wide strategies to advance the network’s impact on RPR priorities. 2) Annual
Network RPR Priority Conference. 3) Network hosted Webinars to accompany Rehabilitation Research-related
FOA’s. We propose developing Network-wide webinars in response to FOAs/RFAs of particular relevance to
rehabilitation researchers. AIM 4. Document, synthesize, and analyze infrastructure outcomes and impact.
To document the incredible work happening across the network and help tell the story that the Network is greater
than the sum of its parts, experienced evaluation and data collection services are needed. The CC has
demonstrated expertise in large-scale multi-center evaluation. We propose to provide Network data coordination
services to collect, analyze, and transform data into actionable insights to accelerate the impact of Network
infrastructure and components.